Parks & Pediatrics Fit Together: Translating knowledge into action for child obesity treatment in partnership with Parks and Recreation

PROJECT SUMMARY
Pediatric obesity remains a significant public health problem affecting one in six US children, yet line evidence-
based pediatric obesity treatments are not widely available in real-world settings. A key barrier is the
sustainability of pediatric obesity interventions, particularly after research studies conclude. To maximize the
health impact of pediatric obesity interventions in diverse settings, there is a critical need to understand what
factors affect sustainability. The parent grant is currently conducting a type 2 hybrid trial to develop (Aim 1) and
test (Aim 2) an implementation toolkit (The “Trailguide”) for Fit Together, a pediatric-obesity intervention, at two
new sites and develop a dissemination strategy (Aim 3) for a broader audience (R01HD100417). All
components of the implementation toolkit are informed by the Fit Together pilot data and are consistent with
current recommendations. However, existing data on pediatric obesity program sustainability is limited, and
sustainability data collection at Fit Together pilot sites was disrupted by COVID-19 related program closures.
The absence of program-specific data to guide effective sustainability strategies represents a clear evidence
gap, and a key barrier to future dissemination. The overarching goal of the proposed supplement is to develop
effective, evidence-based strategies to support sustainability of pediatric obesity interventions. Our primary
objective research is to create an evidence base for effective sustainability of the Fit Together intervention, and
enhance the dissemination plan (Aim 3) of the parent study. We will achieve this objective through the
following specific aims: (1) Identify and describe facilitators and barriers to sustainability for the Fit Together
intervention, informed by the Sustainability Framework; (2) Refine the implementation toolkit by matching
sustainability barriers to strategies using the Program Sustainability Assessment Tool (PSAT) Action Items and
partner listening sessions. We will use explanatory sequential mixed methods, adding additional data collection
from the pilot sites to the sites included in the parent grant. We will first quantitatively identify barriers and
facilitators of sustainability using data from the PSAT. These findings will guide the development of a semi-
structured interview guide for program directors and coordinators (n=24). For Aim 2, we will conduct a 1.5 to 2
hour facilitated listening session with Fit Together program directors and coordinators to receive feedback on
sustainability strategies for the refined implementation toolkit. The proposed work is expected to have a
positive impact because it will facilitate dissemination of under-utilized recommendations for pediatric obesity
treatment.

Public health relevance
PROJECT NARRATIVE Pediatric obesity remains a significant public health problem affecting one in six US children, yet evidence- based pediatric obesity treatments are not widely available in real-world settings. A key barrier is the sustainability of pediatric obesity interventions, particularly after research studies conclude. The proposed supplement aims to develop and incorporate evidence-informed strategies for long-term sustainability into an implementation toolkit for a pediatric obesity intervention, facilitating the dissemination of under-utilized recommendations for pediatric obesity treatment.